Innate immune sensors, inflammasomes, and inflammasome-mediated processes in cancer

ABSTRACT
Innate immune sensors and inflammasomes drive an immune response, primarily providing protection against
microbial infections and mediating control over sterile insults. However, aberrant innate immune signaling is
associated with the pathogenesis of several inflammatory and metabolic diseases, neurodegeneration, and
cancer. In the United States, colorectal cancer is the second most common cause of cancer deaths. Innate
immunity is a major player in the colon, and thus understanding how innate immune pathways contribute to the
various stages of tumor development will be key to improving cancer treatment strategies. We have an extensive
track record of discoveries related to innate immune sensors and their role in colitis-associated colorectal cancer.
We now seek to continue and expand this research program. The primary focus of this application is to unravel
the key mechanisms of novel innate immune sensors and inflammasome regulators discovered in our lab
recently and their crosstalk with cell death regulators in the development of colorectal cancer. Basic science
supporting this area of research is critical to understanding the fundamentals of innate immune responses. This
understanding lays the foundation to explain how defects in these sensing systems lead to the development of
disease in humans. Moreover, as the molecules we are studying are central drug targets, our studies will be
translated into the development of new therapeutics to treat several devastating diseases.

Public health relevance
PROJECT NARRATIVE The innate immune system can impact all aspects of cancer, from tumor initiation to growth and metastasis. This research program will build on our earlier seminal discoveries related to innate immune sensors and their role in colitis-associated colorectal cancer. We will improve understanding of the role of innate immune sensors, inflammasomes, and inflammasome-mediated processes in cancer to shape future cancer treatment strategies.